ReMOTE-BP: Research and Mentorship for Optimizing Treatment and Evaluation of Blood Pressure

SUMMARY
Controlling chronic hypertension reduces a patient’s risk of developing life-threatening conditions over time.
Traditionally, measures like home blood pressure monitoring and ongoing clinical support to provide counseling
or medication adjustments are used to keep hypertension under control. However, the time, resources, and
expertise required for such measures are often out of reach for patients of low socioeconomic status for whom
financial and/or logistical challenges present challenges to frequent in-person care. One solution is to develop a
chronic care model that includes team-based care that is primarily accessed remotely for patients with
hypertension. I am currently conducting a large PCORI-funded clinical trial called Comparing Hypertension
Remote Monitoring Evaluation Redesign (CHARMED, HM-2022C2-28339) to test the impact of one such model
on patient engagement and outcomes. The current proposal complements this work by conducting systematic
economic analyses of the costs associated with implementing that care model within the 25 safety net health
systems involved in the trial. The majority of patients cared for at safety net health systems are of low
socioeconomic status; thus, a focus on the costs incurred and challenges faced by these systems is more likely
to inform improvements in caring for the patient populations most in need of such advances. In Aim 1, the project
team, led by Dr. Elaine Khoong, one of my direct mentees, as well as Dr. Dhruv Kazi, will collect data on costs
associated with equipment and utilization changes, including time-driven activity-based costing to account for
personnel time spent learning and implementing the interventions. Dr. Khoong will compare bottom-line costs
across all arms of the CHARMED trial (PCORI HM-2022C2-28339). In Aim 2, Drs. Lina Tieu and Lisa Ochoa-
Frongia, also my mentees, will lead a study of the relationship between behavioral health care—to treat
conditions like depression or anxiety, which are associated with higher risks of hypertension and related
morbidity—and the clinical outcomes of hypertension patients in the ongoing clinical trial. Again, results will be
compared across arms of the CHARMED trial (PCORI HM-2022C2-28339). Together, this work promises to
advance patient-oriented research toward interventions that effectively control chronic hypertension within the
context of safety net health systems. In leading this work, I continue my commitment to mentoring the next
generation of scientists focused on patient-oriented research, including numerous opportunities for trainees to
build and implement skills in implementation science, informatics, health communication, embedded/learning
health systems research in safety-net health systems, pragmatic clinical trials, and gain experience in robust,
longitudinal patient, family, and community engagement approaches.

Public health relevance
NARRATIVE Team-based, remote-accessible care for chronic hypertension promises to better meet the needs of patients and improve clinical outcomes, particularly among those served by safety net health systems. This work proposes a systematic analysis of the costs of implementing such interventions and considers the relationship between providing behavioral care for depression or anxiety and the clinical outcomes of those with chronic hypertension. The results will inform how novel team-based interventions are implemented within the unique context of resource-constrained safety net health systems. Conducting this research will enhance the skills of early-career investigators committed to using innovative digital tools to address health disparities.